Priorities Aligned Deprescribing for Persons Living with Dementia and their Caregivers

Project Summary
Title: Priorities Aligned Deprescribing for Persons Living with Dementia and their Caregivers
Persons living with dementia (PlwD) have a significant burden from multiple chronic conditions and
overmedication, and particularly benefit from deprescribing to reduce polypharmacy. Deprescribing is a
systematic process to reduce medications with unacceptable harms or lack ofbenefit in the context of a
patient’s overall status and goals and preferences for care. Patient Priorities Care (PPC) is an evidence-
based approach to identify outcome goals and care preferences (health priorities) and align care to meet
those priorities. Deprescribing is targeted towards therapies that are misaligned with priorities. Less is
known about how PPC works in thecontext of clinician, caregiver, and persons living with dementia (PlwD).
Aligning all three goals could be crucial for successful, safe deprescribing in the setting of dementia. To
facilitate the adaptation of the PPC approach to the context of deprescribing for PlwD, we will address the
following research questions: Q1) How does the identification of patient priorities facilitate deprescribing for
PlwD and their caregivers? Q2) How are blended (PlwD and caregiver) outcome goals and caregivers’ care
preferences interpreted and used by clinicians? Q3) How do clinicians make treatment decisions to reduce
or stop medications based on the misalignment of drugs with priorities that include blended outcome goals
and caregiver preferences? Q4) What are the adverse drug withdrawal events (ADWEs) that occur from
deprescribing medications based on patient priorities aligned care decisions? To answer these questions,
we propose the following study aims: Aim 1: Conduct a pilot randomized clinical trialwith 50 PlwD and
caregiver dyads and their clinicians to compare the PPC approach and usual care to identify differences in
post-encounter medication changes, treatment burden, and shared decision making. We will also compare
differences in medication changes based on documentation of care preferences and goals by patients,
caregivers, or both. (Q1) Aim 2: For PPC participants, we will conduct cognitive-task-analyses with primary
providers to understandtheir sense-making and communication approaches related to deprescribing
decisions in relation to the identified health priorities. (Q2, Q3) Aim 3: For all participants, we will conduct a
post-encounter follow up televisit to identify and categorize ADWEs. (Q4) The study results willinform the
processes of how clinicians make decisions about medication misalignment with priorities and the extent to
which those decisions result in ADWE. Findings will also provide feasibility and effect size data to inform a
larger clinical trial of Patient Priorities Care, testing itseffectiveness and safety for deprescribing for PlwD
and their caregivers.

Public health relevance
Project Narrative Title: Priorities Aligned Deprescribing for Persons Living with Dementia and their Caregivers We will conduct a randomized clinical trial with 50 older adults living with dementia and their caregivers to determine if a priorities-aligned approach to dementia care results in safe and effective deprescribing compared to usual care. Participant dyads randomized to the patient priorities care approach will receive an encounter with a facilitator who identifies health priorities (values, outcome goals, and care preferences) followed by an encounter with their primary careprovider who will recommend medication changes that align with the identified priorities. Duringa three-month follow up, we will compare adverse drug withdrawal events, changes in medications, and self-reported treatment burden.